Epidemiology of xylazine-associated health harms: a cohort study of people who have injected drugs

Xylazine is a veterinary sedative that has no approved human use but that has, over the past half-decade,
become increasingly prevalent in the United States’ illicit drug supply, often mixed with fentanyl. In a recent
warning to stakeholders, the FDA identified risks associated with xylazine use, including that: 1) xylazine can
cause respiratory depression and overdose which cannot be reversed by naloxone; 2) xylazine cessation can
lead to severe withdrawal, potentially impeding treatment for opioid use disorder, and 3) xylazine use has been
linked to wounds and severe necrotic skin ulcerations. There is an urgent need for rigorous epidemiologic data
on xylazine use and associated health effects to inform public health response, treatment, and harm reduction.
However, the epidemiology of xylazine use and its associated adverse health outcomes such as wounds and
overdoses are poorly characterized. Our pilot study will provide among the first rigorous estimates of the
association of xylazine use with adverse health outcomes, and will examine drug use behaviors that may
exacerbate or mitigate these xylazine-related harms. Our aims specifically focus on three hypothesized
xylazine-associated adverse health outcomes: 1) wounds and skin necrosis; 2) drug overdose; and 3) all-
cause emergency and hospital visits and the hospital bills incurred because of those visits. These aims will be
accomplished with infrastructure of the ALIVE study: a 30+ year observational cohort of community-recruited
adults living in the Baltimore area who have a history of injection drug use (7,8). Enrolled participants attend
twice-annual study visits at which they complete questionnaires assessing substance use and health.
Beginning in 2025, urine samples will be collected from all participants for rapid, on-site xylazine and fentanyl
testing. Linkage to Maryland’s Health Information Exchange (HIE) allows complete ascertainment of hospital-
and emergency-department based healthcare utilization including all associated dates, locations, and
diagnosis and procedure codes. To this existing infrastructure, we will add: 1) a supplemental questionnaire
with detailed questions about xylazine us; and 2) a standardized direct-observation wound assessment
protocol developed in collaboration with an expert on wound care for people who use drugs. If successful, our
pilot will facilitate future research examining trends in the epidemiology of xylazine, including the prevalence
and correlates of use and health consequences, as well as harm prevention and treatment.

Public health relevance
The FDA and CDC have issued recent warnings that xylazine and medetomidine have become increasingly prevalent contaminants of illicit fentanyl and other drugs in the U.S., and that use of these drugs may be associated with overdose, withdrawal, and the development of severe wounds. Our study will provide among the first rigorous estimates of the association of xylazine and medetomidine use with these adverse health outcomes and resulting health care costs and will examine drug use behaviors that may exacerbate or mitigate these harms. Our findings can provide evidence to public health agencies and clinicians on the prevention, management, and treatment of the increasingly prevalent harms of xylazine and medetomidine.